Improving Access to Research and Training (IMPACT)

Project Summary
Historically in the U.S., students from underrepresented backgrounds earn a disproportionately smaller
percentage of doctoral degrees in the biomedical, behavioral, clinical and social sciences, compared to
students from majority backgrounds. The low numbers of racial and ethnic minorities in biomedical, behavioral,
clinical and social sciences graduate educational programs and, in turn, the workforce has profound
implications for science. Because “minorities” will become the majority of the U.S. population by 2050, a more
diverse doctoral prepared workforce is even more critical; thus, it is imperative to develop innovative programs
to recruit students from underrepresented backgrounds to pre-doctoral academic programs. Long-term, the
proposed “Improving Access to Research and Training” (IMPACT) program is an interdisciplinary collaboration
aimed at increasing the diversity of the research workforce that addresses cardiovascular, pulmonary,
hematologic, or sleep disordered conditions by: (1) Providing a mentored research experience to
undergraduate students from traditionally underrepresented backgrounds, matched to the scholar’s area of
interest, with the goal of providing early exposure to research programs with a cardiovascular, pulmonary,
hematologic, or sleep disorder focus; and (2) Transitioning the IMPACT scholars into graduate school
programs to enhance the diversity of the doctoral prepared workforce in biomedical, behavioral, clinical and
social sciences. The IMPACT program will be an annual 8-week research intensive summer program in the
Penn State College of Nursing (CON) and College of Health and Human Development (CHHD). The IMPACT
program is designed to inspire cohorts of 10 undergraduate students (5 undergraduate and 5 health
professional) from underrepresented racial and ethnic groups, as well as students from inhibited educational
backgrounds, to pursue a career as a research scientist. In addition to immersion into a funded program of
faculty-mentored research, the scholars will attend seminars, complete assignments, and acquire professional
development skills necessary to complete a competitive pre-doctoral application. The long-term objective of the
program is to increase the number of future PhD level scientists from underrepresented backgrounds who
pursue a successful research career, therefore increasing the diversity of the research workforce addressing
cardiovascular, pulmonary, hematologic, or sleep disordered conditions. Our expectation is that the greater
diversity of the workforce will impact both policy and practice and, in turn, potentially reduce health disparities
in those conditions through education and research.

Public health relevance
Narrative The overall goal of the Improving Access through Research and Education (IMPACT) program is to increase the number of future PhD level scientists from underrepresented backgrounds through participation in an annual 8-week summer mentored training experience that provides critical exposure to the research process and tools necessary to complete a competitive pre-doctoral application and successful admission to graduate school. Long-term, this program aims to increase the diversity of the research workforce that addresses cardiovascular, pulmonary, hematologic, or sleep disordered conditions in particular, and, in turn, reduce health disparities in these areas through education and research. skills development.